Rescuing neurovascular coupling to protect neuronal plasticity and cognition

Summary
Growing evidence points towards the contribution of altered brain microcirculation to cognitive impairment and
dementia observed in Alzheimer’s disease (AD) and AD-related dementia (ADRD). Yet, the lack of approaches
to image the small cerebrovasculature and investigate its function has hampered our progress in understanding
the pathological sequence of vascular cognitive impairment and dementia (VCID). The earliest signs of AD and
VCID in patients and mouse models typically involve deficits in spatial and short-term memory—cognitive
functions that are critically sustained by synaptic plasticity in the hippocampus. Neurons have limited energy
reserves and thus rely on a “just-in-time” neurovascular coupling (NVC) strategy in which active regions signal
to the microvasculature to locally dilate and increase local blood flow. Patients and mouse models of AD or
CADASIL, a monogenic archetypal form of VCID, show an early deterioration in NVC. Our previous studies have
identified a molecular defect at play in capillary endothelial cells and developed a therapeutic approach that
acutely restores NVC in the mouse model of AD and CADASIL. Specifically, we found that systemic injection of
phospholipid PIP2 is sufficient to rescue neurovascular deficits by enabling Kir2.1 channels to act as sensors of
increases in external K+—a product of neuronal activity—and transduce this into a vasodilator electrical signal
that rapidly propagates to upstream arterioles, driving vasodilation to produce local hyperemia. Our
multidisciplinary team, with complementary expertise in cutting-edge imaging of brain microcirculation and
synaptic plasticity underlying learning and memory processes, will test the hypothesis that NVC restoration will
mitigate the synaptic plasticity deterioration in the hippocampus, and its behavioral consequences, observed in
AD. We further propose to investigate and compare these functions in CADASIL, a vascular driven form of ADRD.
To attain this goal, we will advance our PIP2-based strategy to chronically restore NVC in AD and CADASIL
models, and assess the treatment efficiency by developing innovative imaging approaches ex vivo, with a novel
intact capillary-arteriolar (CaPA) preparation established by our group, and in vivo using implanted graded-index
(GRIN) lenses combined with 2-photon microscopy to investigate NVC in the hippocampus. Ultimately, we will
measure the effect of NVC rescue on hippocampal synaptic plasticity deterioration caused by AD and CADASIL
conditions, and use contextual fear conditioning as a behavioral readout. Completing this study will help elucidate
the mechanisms linking NVC dysfunction to dementia in AD/ADRDs, and NVC restoration as a potential therapy.
The proposed work has the potential to provide a paradigm-shifting view on how brain microcirculation sustains
learning and memory processes.

Public health relevance
Narrative Neurons in the brain have few energy reserves and therefore depend on local blood flow through arterioles and capillaries for a continuous supply of nutrients. A deficit in cerebral blood flow hemodynamics is an early feature of Alzheimer’s disease and cerebral small vessel disease—a leading cause of stroke and age-related cognitive decline—which suggests that cerebrovascular dysfunction has a key role in the pathogenesis leading to dementia. Here we describe how rescuing the coupling between neuronal activity and local blood flow regulation protect synaptic plasticity and mitigate cognitive impairment. Therefore, this work not only advance the mechanistic understanding of small vessel vascular contributions to cognitive impairment and dementia, but also opens the development of a novel treatment to improve cerebral blood flow in Alzheimer’s disease and cerebral small vessel disease conditions.